Engineering Immune Engagers

PROJECT SUMMARY/ABSTRACT
Natural killer (NK) cell engagers are a promising anticancer therapy that potently leverages the immune system
while providing an exceptional safety profile. Trispecific killer cell engagers (TriKEs) are NK cell engagers that
mediate NK cell killing of tumor cells through multispecific binding. TriKEs contain a tumor binding domain, an
IL-15 cytokine, and a CD16 engager. The IL-15 and CD16 engager stimulate robust NK cell activation and
tumor cell killing while the tumor binding domain targets the therapy to the tumor microenvironment. Expansion
of the TriKE platform to target new tumor-associated antigens requires integration of novel TriKE tumor binding
domains. This process is bottlenecked by difficulties preserving TriKE functionality and developability (i.e.
sufficient stability, aggregation, and recombinant yield for therapeutic use) upon the addition of a new tumor
binding domain. This project will transform the TriKE discovery process by interrogating the impact of
specific tumor binding domain properties on the resultant TriKE’s functionality and developability,
including use of innovative hyperstable miniproteins. Specifically, Aim 1 will investigate the impact of
tumor binder scaffold architecture by comparing the performance of several different scaffolds within TriKEs,
including antibody fragments and hminiproteins. Aim 2 will investigate the impact of preemptively optimizing
tumor binder stability and recombinant yield before insertion into TriKEs. This will be accomplished by
systematically varying tumor binder stability and recombinant yield and quantifying the impact on TriKE
functionality and developability. These investigations will involve the production and characterization of
experimental tumor binding domains and TriKEs targeting B7-H3, an established tumor-associated antigen.
The primary goal of this work is to inform the design of TriKE tumor targeting domains, thereby streamlining the
expansion of the platform to new therapeutic targets. Furthermore, this project will advance the development of
TriKEs as a therapeutic option for B7-H3 positive cancers.

Public health relevance
PROJECT NARRATIVE Immune cell engagers, including trispecific killer engagers (TriKEs), are an emerging class of anticancer therapeutics that stimulate patient immune cells to kill malignant cells. This project will systematically evaluate the impact of tumor engager scaffold architecture, stability, and expression on TriKE performance within the context of B7-H3, a known cancer marker. This project will continue to advance cancer treatment by elucidating the engineering principles underlying the optimization of TriKEs and other immune cell engagers as well as identify superior B7-H3 TriKEs.